Defining locus coeruleus-norepinephrine (LC-NE) circuits in feeding

PROJECT SUMMARY
Overeating is a major contributor to excessive weight gain, involving the hypothalamus and innervating brain
systems that control reward, motivation, learning and emotion. Accumulating clinical data indicate that
disruptions to the norepinephrine (NE) signaling system underlie key aspects of obesity. NE stimulants are
currently the most effective therapies for weight loss, but the precise neural circuits that underlie this regulation
of feeding remain largely unresolved. The goal of this proposed K99-R00 research is to dissect the role of the
locus coeruleus (LC) to lateral hypothalamus (LHA) noradrenergic circuit in feeding and dietary obesity. The
central hypothesis is that increased LC-NE activity will suppress feeding through inhibition of LHA hunger-
promoting neurons. The basis for this hypothesis comes from the candidate’s preliminary data, together with
published findings. To test the central hypothesis, the candidate will carry out three Specific Aims: (1) Identify
the natural population activity patterns of LC-NE neurons during feeding behaviors; (2) Identify the hypothalamic
cell types involved in LC-NE suppression of feeding; and (3) Determine the involvement of the LC-LHA
noradrenergic circuit in the physiology and treatment of obesity. These aims will be accomplished using state-
of-the-art technologies developed and used by the candidate’s mentoring team, including wireless fiber
photometry to visualize neuronal activity, optogenetics tools to manipulate neural activity, and devices for high-
resolution measurements of feeding behavior. This career development award will build on the candidate’s skills
in behavioral pharmacology and systems neuroscience, and will facilitate the candidate’s long-term career goal
of developing an independent research program focused on the NE circuits underlying feeding. The ultimate
goal of this research is to inform the development of novel treatment strategies that activate specific LC-NE
circuits to suppress feeding without incurring the off-target side effects observed using strategies that affect the
entire noradrenergic system.

Public health relevance
PROJECT NARRATIVE More than half of American adults are overweight or obese. Current weight-loss therapies targeting norepinephrine signaling have adverse side-effects, due in part to their broad effects throughout the nervous system. The goal of this research is to identify specific norepinephrine neural pathways that suppress feeding, with minimal off-target effects, thus revealing new avenues for development of improved weight loss therapies.